KSHV Epigenetic Regulation

Project Summary/Abstract
While KSHV can be detected in blood and occasionally in semen, it is frequently secreted in
saliva which is believed to be the main route of spread. Nearly 25 years after the identification of
KSHV, however, the initial steps in KSHV oral infection and the expressions of host and KSHV genes
are still poorly understood. Our main question is: while KSHV establishes latency in most cells and
KS lesions by default, why does it lead to spontaneous lytic replication in oral epithelial cells and oral
lesions? Our hypothesis is: this difference is due to the differences of viral epigenetics and
genomics. As the previous grant has been primarily focused on the epigenetic regulation of KSHV,
the current study will characterize the high-order genomic organization of KSHV and investigate the
transcriptomic and epigenomic regulations of KSHV at the single cell level using 3D organotypic oral
tissue infection model that closely resembles in vivo oral transmission.

Public health relevance
Project Narrative The goal of this study is to characterize the high-order genomic organization of KSHV and to investigate the transcriptomic and epigenomic regulations of KSHV at the single cell level using three-dimensional (3D) organotypic oral tissue infection model that closely resembles in vivo oral transmission. This will provide insights into KSHV oral transmission and complication.